Posaconazole: Retrospective Review of Clinical Use and Therapeutic Monitoring

Data collection of NIH clinical center patients who have received posaconazole has been completed. A second abstract was accepted for a meeting this fall (ACCP 2012). I am currently in the process of writing a manuscript for submission for those patients <12 years of age who received Posaconazole for submission to PIDJ. ACCP 2012, Accepted Abstract Jancel T, Penzak SR, Shaw PA, Malech HL, Freeman AF, Holland SM. Review of the use and therapeutic drug monitoring of posaconazole in adults. American College of Clinical Pharmacy (ACCP) Annual Meeting. October 2012. ICAAC 2011, Accepted Abstract: Jancel T, Penzak SR, Shaw PA, Malech HL, Freeman AF, Holland SM. Review of the use and therapeutic drug monitoring of posaconazole in pediatric patients. 51st Interscience Conference on Antimicrobial Agents and Chemotherapy (ICAAC). Chicago, IL. September 2011.